The Human Temporal Bone Laboratory Resource for Basic and Applied Inner Ear Sciences

ABSTRACT
In the present proposal we will preserve, process and make available human ear tissue to inner ear basic
researchers they will be able to compare with their animal models. The use of celloidin, microdissected tissue
for immunohistochemical and quantitative techniques will be instrumental in driving basic animal inner ear
research into the understanding of human ear pathology and has high potential for the development of effective
drug therapies for restoring auditory and vestibular function. In Specific Aim 1) we will improve access for the
auditory and vestibular research community to human ear tissues from temporal bone specimens. We will
improve and promote timely procurement, preparing and processing of new specimens, and appropriate re-
processing of archived specimens. We will distribute a limited number of well-prepared laboratory tissues to
funded researchers who lack adequate access to facilities for human temporal bone preparation. We will also
exploit use of the Registry for information about currently archived tissues and their access by the community,
and promote collaborations between researchers seeking to validate animal models for human relevance.
Specific Aim 2) We will optimize tissue preparation techniques. We will include molecular and cellular marking
and visualization techniques that allow direct comparisons of fresh and archived human tissues with those from
animal models. We will disseminate protocols for procurement, preservation and preparation of human ear
tissues from temporal bones. By doing this we will encourage animal researchers to include human tissues into
their analyses. Specific Aim 3) We will develop tools to exploit new technologies and methods to image and
visualize human middle and inner ears in situ. Targets for imaging techniques will include soft cellular tissues,
membranes and fluids, as well as hard bony tissues. Specific Aim 4) We will provide technical instruction with
hands-on training will be available for investigators, technicians otolaryngology residents, medical school and
graduate students interested in inner ear biology in the temporal bone processing techniques and skills needed
for processing human ear tissues from temporal bones. The materials generate in this proposal will be extremely
useful for the research in basis inner ear research field, in the USA and around the globe.

Public health relevance
NARRATIVE To advance in the temporal bone sciences we will promote and share human ear tissue with basic inner ear researchers. We will provide instruction to the scientific community to handled, acquire, stain and process human ear tissue. We will further develop better techniques to identify cellular components in the human inner ear using immunofluorescence and transmission electron microscopy.